Tracing the lineage histories and differentiation trajectories of individual cancer cells in myeloproliferative neoplasms

Project Summary
In some cancers, intriguingly, the same mutation results in drastically different disease phenotypes in different
patients. An example is a type of blood cancer, known as myeloproliferative neoplasm (MPN), where a single
nucleotide change in the JAK2 gene, may result in either an increase in the number of red blood cells, an increase
in the number of platelets, or scarring of bone marrow tissue, in different patients. The disease outcome is just
as unpredictable. Some patients show no symptoms for decades whereas others rapidly progress to acute
leukemias. This disconnect between genotype and phenotype may be due to the identity of the hematopoietic
stem cell (HSC) in which the mutation first occurs. Not all HSCs are equivalent and some may preferentially give
rise to certain types of blood cells. Additionally, the subsequent expansion of the population of mutated stem
cells may be different in different patients. Therefore, to understand the heterogeneity in disease presentation,
we would like to know when and in which cell the cancer mutation first occurred in each patient, how the
population of mutated HSCs expanded, and to what extent the differentiation trajectory of the cancer cells
deviates from that of the healthy cells. Here, we propose a comprehensive research program to make these
measurements in individual MPN patients. To understand the difference between the cancer cells and the
healthy cells in each patient, we will profile each cell individually. Bulk measurements average over the cancer
cells and healthy cells, and obscure different cell states along the differentiation trajectory. We have recently
developed a technology platform to simultaneously read out the full transcriptome and the cancer mutation in
single cells. We will apply this platform to cells obtained from bone marrow biopsies of MPN patients. To obtain
the history of the expansion of the cancer stem cells in each patient, we will reconstruct the lineage tree of the
HSCs by sequencing the somatic mutations in the whole genomes of individual HSCs. Somatic mutations occur
randomly at each cell division and are passed on to a cell’s descendants. Critically, we will also trace the
differentiation trajectories of the progenies of each HSC by identifying the somatic mutations that uniquely mark
each HSC in our single-cell transcriptomic data. Taken together, these measurements will provide the most
detailed molecular picture of MPN at a single-cell resolution and the most comprehensive molecular history of
cancer progression in individual patients. Finally, to identify and test potential therapies for MPN, we will engineer
animal models whereby lineage histories of individual cells can be obtained without whole genome sequencing.
We will engineer a mouse model of MPN in which individual cells record their lineage histories in their own DNA
by using Cas9 to induce heritable mutations in synthetic target arrays that are transcribed and read out using
sequencing. Our proposal will answer some of the most outstanding and fundamental questions about MPNs
and blood development. Ultimately, our measurements should reveal patient-specific targeted therapies that
preferentially eradicate the cancer stem cells or hinder their differentiation.

Public health relevance
Project Narrative More than 20,000 people in the United States are diagnosed with myeloproliferative neoplasms every year. Currently, we lack the tools to identify which patients will progress to acute leukemias and the only existing cure is allogeneic bone marrow transplant, a risky procedure that is feasible in only a small subset of the patients. Here, we propose a comprehensive research program to characterize individual cancer cells and reconstruct the history of disease progression in each patient, ultimately, identifying patient-specific targeted therapies that eradicate the cancer cells or hinder their growth.